Characterizing clearance mechanisms of TDP-43 and disease associated isoforms

ABSTRACT
Amyotrophic lateral sclerosis (ALS) is a devastating neurodegenerative disease characterized by progressive
loss of upper and lower motor neurons. Over 95% of ALS patients exhibit cytoplasmic mislocalization and
aggregation of the nuclear RNA-binding protein, TDP-43. These aggregates often contain N-terminal or C-
terminal truncated isoforms of TDP-43 along with full length TDP-43 (flTDP-43). It is unclear if these aggregates
are the direct cause of cell death, though reducing cytoplasmic TDP-43 or its isoforms in disease models
improves cell viability. Recently, our lab uncovered a macroautophagy-independent endolysosomal mechanism
that requires the E3 ubiquitin ligase, Rsp5/NEDD4, the ubiquitin segregase chaperone, Cdc48/VCP, and ESCRT
machinery to facilitate trafficking of TDP-43 into multivesicular bodies (MVBs). However, many mechanistic steps
in this process remain unclear including how this pathway relates to a previously defined means of
endolysosomal cytoplasmic protein degradation known as endosomal microautophagy (eMI). Using biochemical,
genetic, and microscopy-based approaches, I will determine the specific interactions, modifications, and cellular
conditions under which TDP-43 is targeted to MVBs in human and neuronal-cell models. These experiments will
uncover new mechanistic detail regarding TDP-43 endolysosomal degradation and eMI. I will also investigate
the degradation mechanism of three TDP-43 isoforms: sTDP-43, TDP-35, and TDP-25. TDP-43 isoforms have
distinct half-lives from flTDP-43 which suggests isoform-specific degradation pathways may exist. Targeted
degradation of disease-specific TDP-43 isoforms may have greater efficacy in disease treatment, while
preserving functional flTDP-43 species thus avoiding loss of function phenotypes. Using our unbiased genome-
wide dot blot screening platform in yeast and candidate-based approaches based on our current work, we will
elucidate the clearance mechanisms of all major TDP-43 isoforms. Collectively, this study will uncover new
mechanistic detail regarding TDP-43 endolysosomal degradation, reveal broader insight into cytoplasmic
proteostasis mechanisms, and advance the search for novel therapeutic targets for ALS and other TDP-43
proteinopathies.

Public health relevance
PROJECT NARRATIVE Proteinopathy of the RNA binding protein TDP-43 occurs in neuronal tissue in many neurodegenerative dis- eases, including in >95% of all ALS cases, where it is understood to be a key driver of the disease. We recently discovered a novel endolysosomal clearance mechanism that facilitates degradation of cytoplasmic TDP-43 via ubiquitin-dependent targeting to multivesicular bodies. Here, I will uncover new mechanistic detail regarding TDP-43 endolysosomal degradation and determine the clearance pathways of disease associated TDP-43 isoforms to reveal broader insight into cytoplasmic proteostasis and potentially identify therapeutic targets for TDP-43 proteinopathies.